PRE-SURGICAL APPLICATIONS OF FUNCTIONAL MRI IN EPILEPSY

This project seeks to validate applications of FMRI in the surgical management of epilepsy by comparing data obtained from FMRI with those using standard mapping and neuropsychometric techniques.